Neural and hemodynamic markers of cocaine reinstatement

[unreadable] DESCRIPTION (provided by applicant): This application studies the effects of intravenous cocaine administration in the brains of rats conditioned to cocaine, with in vivo hemodynamic measurement cross-referenced with c-fos immunoreactivity. The nemodynamic measurements are made using functional magnetic resonance imaging (fMRI), which infers oatterns of brain activity from stimulation-induced changes in the magnetic relaxivity of the local blood and issue. This method is well-established in rat models of somatosensory stimulation, and increasingly popular for analyzing the acute effects of psychoactive drugs. The specificity of the most popular pharmacological MRI method, cerebral blood volume (CBV) imaging with an injected contrast agent, is assessed using the jxtinction-reinstatement rat model of compulsive cocaine abuse. The effects of popular anesthesia treatments on drug-primed relapse behavior and neuronal Fos expression are assessed before fMRI experiments. The goal of this research is to conclusively separate the loci of cocaine-induced neural activity from non-specific cerebrovascular effects in a paradigm that preserves drug-primed reinstatement behavior, which would produce a fMRI-compatible small animal model of cocaine craving and relapse. [unreadable] [unreadable] [unreadable]